ALPHA2 ADRENERGIC RECEPTOR DYSFUNCTION IN PATIENTS W/ REGIONAL LIPOAT

Partial or total lipoatrophy is characterized by insulin resistant diabetes, hypertiglyceridemia, fatty infiltration of the liver, and hypertension. The etiology of this syndrome is unknown. The alpha2 adrenergic receptor is a Gi-dependent system which normally antagonizes the lipolytic effects of beta adrenergic agonists primarily in peripheral fat depots and antagonizes alpha1.